Administration Core

PROJECT SUMMARY/ABSTRACT
The Holden Comprehensive Cancer Center (HCCC) functions administratively as a matrix cancer center, with
administrative staff providing support to 170 HCCC members who have over $23.4 million in direct annual
cancer-related, peer-reviewed, external research support, including $11.0 million from the NCI. The
administrative office of HCCC excels in providing strategic and operational support across the full complement
of services that advance the clinical, research and education missions of HCCC. The outstanding growth and
development that has occurred during this past funding cycle is a direct reflection of the advanced capabilities
of the administrative team to strategically plan, advocate for, grow and refine operations to meet current and
future demands.

Public health relevance
PROJECT NARRATIVE Not applicable